Post-transcriptional regulation of LDLR

ABSTRACT
Elevated plasma LDL cholesterol is the main risk factor in cardiovascular disease (CVD), the
leading cause of death in the United States. Cholesterol levels are regulated by complex feedback
mechanisms that help maintain cellular and plasma cholesterol levels in check. While
transcriptional mechanisms that control cholesterol homeostasis, such as SREBPs and LXRs are
well described, here we describe a novel post-transcriptional mechanism that is involved in
controlling the mRNA stability of Ldlr mRNA. We have identified a family of RNA binding proteins
(RBPs) that target specifically mRNAs and are important in cholesterol homeostasis. We show
that hepatic loss of one or more of these RBPs in the liver results in increased levels of LDLR
mRNA and protein. In Specific Aim 1, we will identify the direct mRNA targets in vivo using CLIP-
Seq and we will perform functional genomics to determine the effect of human variants in the
LDLR 3’UTR. In Specific Aim 2, we will extend our preliminary data showing that loss of one of
our RBPs in the liver profoundly protects from atherosclerosis. Using a ‘humanized’ lipoprotein
mouse atherosclerosis model, we have developed the hypothesis that loss of our RBP in the liver
promotes uptake of LDL particles, thus protecting from atherosclerosis. Further, we hypothesize
that the internalized cholesterol is then preferentially catabolized to bile acids. Thus, our mouse
model will allow us to better understand how the liver channels cholesterol taken up from LDL
particles to ultimately protect from CVD.

Public health relevance
Relevance to Public Health Cardiovascular disease (CVD) is leading cause of death in the United States and represents a significant burden to the national health system. We have uncovered a novel layer of posttranscriptional regulation for LDLR, the determinant of plasma cholesterol and the key driver of CVD, which may result in improved therapeutic interventions.